Stroma penetrating and immune modulating nanoparticles for image-guided therapy of pancreatic cancer

Project Summary
Resistance to therapy is the major challenge for the treatment of pancreatic cancer. Despite recent successes
in immune checkpoint therapy of several human cancer types, pancreatic cancer showed a poor response to the
immunotherapy. Increasing evidence reveals that a dense stromal barrier in pancreatic cancer blocks drug
delivery and intratumoral distribution. The physical barrier of stromal and biological barrier from
immunosuppressive responses further limit the number and function of infiltrating effector T cells. The objective
of this project is to develop a new immunotherapy strategy by co-delivery of tumor penetrating and
immunomodulating theranostic nanoparticles and PD-L1 inhibitors. Our innovative uPAR targeted and stroma
breaking ligand consists of the amino terminal fragment (ATF) of uPA and the catalytic domain of matrix
metalloproteinase-14 (ATFmmp14). It targets multiple cell types in tumors and promotes nanoparticle/drugs
migrating through stromal and extracellular matrix barriers to reach tumor cells. ATFmmp14 conjugated magnetic
iron oxide nanoparticle (IONP) carrying Doxorubicin or SN38 enabled magnetic resonance imaging (MRI) guided
targeted delivery of nanoparticle/drug in tumors, and strong therapeutic effect in pancreatic cancer patient
derived xenograft (PDX) and Kras-driven transgenic mouse tumor models. Notably, targeted delivery of the
theranostic IONPs into tumors promoted infiltration of immune effector cells and decreased immunosuppressive
cells, converting an immune “cold” pancreatic tumor into a “hot” tumor. We further developed an ultrasmall IONP
PD-L1 inhibitor (Nano-iPD-L1) using an engineered PD-L1 blocking peptide. We showed that Nano-iPD-L1
selectively accumulated in pancreatic tumors following systemic delivery. Co-delivery of Nano-iPD-L1 with
ATFmmp14-IONP/drug enhanced intratumroal delivery and significantly inhibited tumor growth in a mouse
pancreatic cancer model. Therefore, we hypothesize that improved drug delivery in pancreatic tumors by co-
administrations of stroma penetrating ATFmmp14-IONP/SN38 and Nano-iPD-L1 leads to a strong therapeutic
efficacy through direct tumor cell killing, modulating immunosuppressive stroma, and blocking PD-L1 function to
generate a strong response from cytotoxic T cells. In the proposed study, we will first investigate and optimize
dose and therapeutic efficacy of co-delivery of ATFmmp14-IONP/SN38 and Nano-iPD-L1 in mouse pancreatic
cancer models (Aim1). Followed by non-invasive MRI to assess theranostic IONP delivery and tumor response
after the combined therapy using ATFmmp14-IONP/SN38 and Nano-iPD-L1 in transgenic mouse and pancreatic
cancer PDX models (Aim 2). Finally, the effects of an enhanced intratumoral accumulation of ATFmmp14-
IONP/SN38 and Nano-iPD-L1 on promoting infiltration of effector immune cells, modulating stromal
immunosuppressive cells and factors, and activating cytotoxic T cells will be investigated in transgenic mouse
pancreatic tumor models (Aim 3). Results of this study should provide us with new targeted theranostic IONPs
and immunotherapy for translation of this novel therapy for advanced pancreatic cancer.

Public health relevance
Project Narrative The outreach goal of the proposed research project is to develop a new combination of targeted drug delivery and immunotherapy for the treatment of advanced pancreatic cancer. Our innovative designs of tumor penetrating and immune modulating theranostic nanoparticles, coupled with a novel nanoparticle PD-L1 inhibitor (Nano-iPD-L1), enable efficient delivery of chemotherapy drugs and immunotherapy agents into stroma-rich pancreatic cancer tissues to destroy drug resistant tumor cells, modulate an immunosuppressive microenvironment into a pro-immune environment, and generate strong immune responses. Results of this translational research project have the potential for the development of a targeted and image-guided cancer therapy that significantly enhances therapeutic efficacy, and activates tumor specific immune response, and improves survival of pancreatic cancer patients.